Genomics & Bioinformatics Module

ABSTRACT
Genomics and Bioinformatics Module
The Genomics and Bioinformatics Module provides investigators comprehensive next generation sequencing
(NextGen) and single cell genomics services for their projects; module services include experimental design,
library construction, sequencing production, data analysis, distribution, and storage. Genome biology is one of
the most powerful approaches for studying complex diseases such as cancer as it enables researchers to gain
a complete and global view of the genome. The invention of NextGen sequencing technologies further
accelerates the advancement of genome biology by increasing the speed, capacity, and accuracy of DNA
sequencing. NextGen sequencing has revolutionized the world of molecular biology, genetics, and genomics
by enabling a broad range of applications: mutation detection, gene expression, epigenomics, etc. As an
established NextGen sequencing core, we have collaborated with many vision research groups and have
obtained excellent results in various types of experiments, such as ChIP-Seq, RNA-Seq, microRNA profiling,
scRNA-seq and mutation detections. In addition to these standard experiments, the module personnel will
work closely with individual groups to develop customized solutions. With extensive experience in molecular
biology, genomics, computation biology, and strong support from the Human Genome Sequencing Center
(HGSC) and Baylor College of Medicine (BCM), the Genomic Core is in a strong position to facilitate the
integration of the diverse groups of vision researchers at BCM and bring cutting edge NextGen and single cell
genomics technologies to each group at low cost.

Public health relevance
NARRATIVE Genomics and Bioinformatics Module The Genomics and Bioinformatics Module is an important resource that addresses the increasing need of the vision researchers at Baylor College of Medicine to access the state-of-the art genomic technologies that are not available in individual laboratories and provides critical bioinformatics support in deciphering the vast amount of data. This module will leverage the expertise, technologies, and resources at the BCM Human Genome Sequencing Center (BCM-HGSC), one of the three major genome centers in the US. In addition to providing service, the module will also serve as a key mechanism to introduce cutting edge genomics and single cell technologies to vision researchers.